Exercise-Associated Signaling Against CNS Aging and Alzheimer's Disease

ABSTRACT
Skeletal muscle has recently arisen as a novel regulators of Central Nervous System (CNS) function and
aging, secreting bioactive molecules known as myokines with proteostasis and metabolism-modifying functions
in targeted tissues, including the CNS. Myokine secretion is heavily modified by exercise, suggesting that
myokine signaling in the periphery may underlie the well documented geroprotective benefits of exercise on
the brain. The following studies address muscle proteostasis, a pathway highly activated during exercise, as a
potential new regulator of the neurocognitive benefits of exercise. We have recently generated a novel
transgenic mouse with enhanced muscle proteostasis via moderate overexpression of Transcription Factor E-B
(TFEB), a powerful master regulator of cellular clearance and proteostasis. We have discovered that the
resulting enhanced skeletal muscle proteostasis function can significantly ameliorate proteotoxicity in the aging
CNS and also improve cognition and memory in aging mice. Enhancing muscle proteostasis also reduced
neuroinflammation and accumulation of AD-associated pathological hallmarks in plaque based and a tau-
based models of AD. We have also identified previously unreported alterations in the transcriptome of skeletal
muscle from patients with AD, as well as potential unique populations of skeletal muscle factors that may be
driving these CNS benefits. In this project, we will determine if enhanced skeletal muscle proteostasis
promotes neuroprotection against AD-associated phenotypes, and using powerful transfer learning and
computational modeling approaches, identify exercise-associated circulating factors as new therapeutic
interventions for the preservation of CNS function during AD.

Public health relevance
PROJECT NARRATIVE Physical activity has extensive and well-documented neuroprotective effects, benefitting cognitive function during healthy aging and reducing the risk of Alzheimer Disease (AD). However, the mechanisms responsible for these benefits remain largely unknown, making identification of the circulating signals that underlie the CNS-targeting benefits of exercise a major advance for developing CNS rejuvenating therapeutics against AD. The following studies address muscle proteostasis, a pathway highly activated during exercise, as a potential new regulator of the neurocognitive benefits of exercise, as well as new therapeutic intervention for preservation of CNS function in AD.